Programmable Off-the-Shelf Dendritic Cells as an Immunotherapy Discovery Platform

Project Summary

Adoptive Cell Immunotherapy using patient harvested T cells engineered against tumor-­specific targets has
ushered in a new therapeutic era. However, the lack of tumor-­specific targets and T cell receptors limits the

addressable cancers. A promising approach for solid tumors uses T cell receptors (TCRs) directed against tumor-­
specific antigens (TSAs) displayed on HLA receptors found on the surface of nearly every cell. Unfortunately,
HLAs are highly polymorphic genes between people. This restricts both the TCRs and TSAs to a small number
of patients. A platform that expands the number of HLA-­restricted TSAs and TCRs will transform the entire
immunotherapy pipeline.

Here, I propose to address this unmet need by generating programmable Dendritic cells (DCs) – professional
antigen presenting cells that function to mature and activate naive T cells. Programmable DCs would permit the
discovery of new TCRs, validation of TSAs, and perhaps be used as "living" vaccines to marshal a patient’s own
immune system against infectious disease and cancer. Thus far, efforts to leverage the potential of DCs have

been limited principally by: (1) an inability to produce cells with HLAs matched to patients;; (2) an inability to
robustly test and validate new TSAs against TCRs;; and (3) an inability to produce "off-­the-­shelf" DCs at industrial
scale.

As a new innovator, my vision is to produce off-­the-­shelf Dendritic Cells pre-­engineered to match any HLA
haplotype (even rare ones) and pre-­encoded with any combination of TSAs. Using this new platform, my group
will search for and validate "universal" TSAs/TCRs that can be used broadly in TCR-­Therapy for any patient.

Specifically, we will focus on peptides expressed from regions of the genome normally epigenetically silenced,
but re-­activated in tumor cells (such as endogenous retroviruses). To reach this goal, we will continue
development of technology enabling the "writing" of millions of base-­pairs of DNA in human induced pluripotent
stem cells (iPSCs). This technology allows direct customization of the large HLA locus of iPSCs in a single step;;
introduction of libraries of potential TSAs;; and integration of synthetic reporter constructs (which are excisable

for safety) for enhancing the in vitro directed differentiation of iPSCs to DCs. Thus, allogeneic programmed DCs
will catalyze a wide variety of immunotherapy applications and expand access of these advanced treatments for
a greater number of patients.

Public health relevance
Project Narrative This proposal will expand access to cell immunotherapies for more people. We will build programmable iPSC- derived Dendritic cells as a way to identify new T cell receptor immunotherapies for cancers and infectious disease. These Dendritic Cells will be "off- the- shelf", HLA- customized, and loaded with potential universal cancer targets.